Newborn Circumcision Care Redesign

PROJECT SUMMARY/ABSTRACT
Circumcision is one of the most common surgical procedures performed in the United States.
Periprocedural risk is lowest, costs are lowest, and health benefits (e.g., decreased risk of urinary tract and
sexually transmitted infections) are greatest when circumcision is performed as a neonatal circumcision (NC)
under local anesthesia, rather than as an operative circumcision (OC) under general anesthesia later in life.
However, young boys for whom an infant circumcision was desired commonly present for elective OC after the
neonatal period. Previous research indicates that boys of lower socioeconomic status have more difficulty
accessing NC such that the increased risks and decreased health benefits of OC disproportionally affect boys
of lower socioeconomic status. Recent data show that changes in Medicaid coverage of NC disproportionately
affect Black/African American boys compared with boys of other racial/ethnic backgrounds. Available data
indicate that both healthcare operational and insurance coverage factors contribute to the disparity in access to
NC. Chicago-Area clinician interviews have identified multiple operational barriers to NC, including clinical
logistical challenges and lack of standardized processes that compound substantial variation in NC
reimbursement that dis-incentivizes some birth hospitals from uniformly offering NC.
The proposed study aims to address the operational barriers to providing NC to desirous families. The
World Health Organization’s evidence-based Standards and Procedures for high-quality, high-volume NC
programs will be used as a framework (developed for low- and middle-income countries) and adapted for
utilization in multiple clinical settings in the United States (US). The goals of this proposal are to (1) leverage
the WHO Standards and Procedures to develop and implement safe, efficient, and contextually-adapted NC
programs at 3 hospitals that promote equity of NC; (2) evaluate each NC program’s impact on patient
outcomes; and (3) provide a cost analysis of the NC program to support dissemination. A multidisciplinary
team (pediatrics, obstetrics, pediatric urology, health services research, health economics, and global health)
has been assembled to execute the study. Findings from this study will provide US birthing hospitals with
examples of safe, efficient, and contextually adaptable NC programs, based on the evidence-based WHO
Standards and Procedures. These examples will include cost analyses from both hospital and patient
perspectives to facilitate dissemination. Ultimately, by implementing NC programs that overcome both
structural and health system barriers, equity in NC should improve.

Public health relevance
PROJECT NARRATIVE Currently, not all families who want a circumcision for their newborn sons are able to obtain the procedure soon after birth, even though this is the safest time for a circumcision to be performed. The goal of this study will be to create and test a new, more efficient way to deliver newborn circumcision care. The public health impact of this study will be to provide a way for newborn circumcisions to be done for more families who want one, which will particularly benefit families of lower socioeconomic status.